EVALUATION OF HIGH DOSE I.V. THERAPY WITH BETASERON IN MALIGNANT GLIOMAS

This study will determine the individual patient maximum tolerated dose (MTD) of Betaseron when given by intravenous infusion three times weekly in doses escalating from 90 to 720 x 10 IU for 5 weeks or longer in patients with malignant glioma. It will determine the therapeutic effect and safety of Betaseron therapy when given at MTD in this regimen.